FHOD3 Regulation of Autophagy Pathway in Cardiomyopathy

Project Summary
Cytoskeletal remodeling and turnover are central contributors to left ventricular (LV) remodeling that underlies
cardiomyopathy and heart failure. Formin homology 2 domain containing-3 (FHOD3) is a member of the formin
protein family that regulates cardiac actin filament formation. FHOD3 is required for sarcomere formation during
embryonic heart development and remodeling of the adult heart. We identified a common variant, FHOD3V1151I
(rs2303510), associated with hypertrophic cardiomyopathy (HCM). To investigate the mechanistic basis of the
association of FHOD3V1151I with HCM, we used CRISPR to create an Fhod3V1151I mouse model and discovered
that Fhod3V1151I mice have normal heart size and contractile function in the absence of hypertrophic stimulus.
Provocatively, though, Fhod3V1151I mice develop excessive cardiac hypertrophy and physiologic findings of heart
failure, including activation of the fetal gene program with pressure overload. Using our state-of-the-art
Autophagy Detecting Nanoparticle imaging technology we demonstrate that Fhod3V1151I mice have impaired
autophagy. The role of autophagy defects are recognized in cardiomyopathy and are therefore emerging as an
important modifier to the cardiac response to stress that could impact the development of HCM and associated
symptoms. In this proposal, we will compare the response of Fhod3V1151I mice to autophagy stimulation
(rapamycin) and inhibition (bafilomycin). Furthermore, we will test the role of the Fhod3 variant in the context of
a mutation in Mybpc3, which serves as a mouse model of HCM known to have defective autophagy. Because
Fhod3V1151I mice have reduced levels of the early autophagy regulator Beclin, we will assess whether the
recombinant protein tat-Beclin can rescue the autophagy defect caused by Fhod3V1151I in the context of a Mybpc3
mutation that causes HCM. Finally, since extracellular vesicle (EV) formation is a direct consequence of
autophagy and we demonstrate significant defects in EV production with FHOD3V1151I, we will evaluate the effects
of FHOD3 on cellular component trafficking related to autophagy and EV production. Considering that the
FHOD3V1151I allele is carried by approximately one third of humans of all races and ethnicities, and because of
its established association with HCM as a risk allele, the potential impact of this study on human heart failure is
substantial. By defining the mechanisms by which FHOD3 variants modify cardiac autophagy and LV
remodeling, including the role of genotype-defined personalized medicine strategies that may modify this genetic
risk, these studies have the potential to translate into improved heart failure management.

Public health relevance
Narrative Analyses of humans with enlarged hearts and heart failure have identified FHOD3 as a gene that influences the age when someone develops hypertrophic cardiomyopathy. The collaborative research proposed here will determine how FHOD3 gene variants influence the heart’s response to stress leading to heart failure in humans. By defining how heart cells respond to stress, these studies will provide new insights into how the heart can fail and could lead to new strategies to prevent heart disease.